Food Protection Rapid Response Team and Program Infrastructure Improvement Protot

Food Protection Rapid Response Team and Program Infrastructure Improvement Prototype Project PA-09-183 Page 1 of 1 DEPARTMENT OF STATE HEALTH SERVICES (DSHS) DIVISION FOR REGULATORY SERVICES ENVIRONMENTAL AND CONSUMER SAFETY SECTION AND OFFICE OF THE TEXAS STATE CHEMIST PROJECT SUMMARY The aim of this grant is a food-borne illness Rapid Response Team that, through the development of various programmatic enhancement and improvements, along with improved coordination and communication, will provide consumers with a safer food supply. The overarching goal for the DSHS food safety program is to be considered among its peers as the "gold standard". Achieving this goal has the potential to guarantee credibility with stakeholders, while at the same time positions the program to become a benchmark for other state food safety programs. A future goal for the program is to become certified by the FDA, in the same manner as the DSHS Meat Safety Assurance Program is by the U.S. Department of Agriculture (USDA)/Food Safety Inspection Service (FSIS). One of the program's priorities will be to conduct the self-assessment and meet the 10 Manufactured Foods Regulatory Program Standards (MFRPS) within the three-year period of the grant. DSHS's Division for Regulatory Services and the Office of the Texas State Chemist (OTSC) will accomplish this through the following goals: Goal 1: Development of a Rapid Response Team (RRT) capable of rapidly responding to food-borne illness outbreaks for identification of the responsible food and elimination of the hazard to reduce further exposure; Goal 2: Attainment of the Manufactured Foods Regulatory Program Standards (MFRPS); Goal 3: Improved laboratory capacity for the testing of human and food (including feed) specimens; Goal 4: Improved communication and education of stakeholders to improve prevention measures;improve coordination of inspections and investigations with our counterparts, laboratory and epidemiology to enhance existing intervention, response, and mitigation activities. Goal 5: Development of the ability to share inspectional data with the FDA needed to strengthen risk management procedures.

Public health relevance
Food Protection Rapid Response Team and Program Infrastructure Improvement Prototype Project PA-09-183 Page 1 of 1 DEPARTMENT OF STATE HEALTH SERVICES (DSHS) DIVISION FOR REGULATORY SERVICES ENVIRONMENTAL AND CONSUMER SAFETY SECTION AND OFFICE OF THE TEXAS STATE CHEMIST Project Narrative/Relevance The State of Texas has seen at least three large emergency events in the past year, two of which were nationwide food-borne illness events (Salmonella saintpaul and Salmonella typhimirium). The Texas Department of State Health Services (DSHS), Office of the Texas State Chemist, and the U.S. Food and Drug Administration over the past few years have formed a communication network in the event of emergency situations. This grant will allow the State of Texas to develop a formal mechanism for responding to emerging events quickly and in a pre-planned, coordinated manner.